Gestational Diabetes Mellitus, Perinatal Depression, and Offspring Neurodevelopmental Phenotype - Diversity Supplement

PROJECT ABSTRACT
This diversity supplement application aims to support candidate training aims focused on prenatal maternal
adversity, data analysis, and scientific communication to support the candidate’s long term goal of pursuing a
career in Clinical Psychology focused on mental health interventions among perinatal populations with
adversity. During this award, the candidate will examine the moderating role of prenatal maternal adversity on
the association between gestational diabetes mellitus (GDM) and perinatal maternal depression in a
prospective pregnancy cohort at NYU Grossman School of Medicine (4R00HD103910-03). Through the
training and research aims embedded in this award, the candidate will develop expertise in longitudinal
perinatal research in understudied communities to understand the impact of perinatal adversity.

Public health relevance
PROJECT NARRATIVE This diversity supplement will examine the moderating role of prenatal maternal adversity on the association between gestational diabetes mellitus (GDM) and perinatal maternal depression in a prospective pregnancy cohort at NYU Grossman School of Medicine.